Sapacitabine therapy to create synthetic lethality in DNA repair-deficient CLL

DESCRIPTION (provided by applicant): There has been remarkable progress in the treatment of CLL during the last decade. The introduction of fludarabine and other purine nucleoside analogs generated a significant improvement in responses relative to alkylating agents.1-3 Subsequently combinations of these two classes of agents, in particular fludarabine and cyclophosphamide, were proved superior to single agent fludarabine.4-6 Recently strategies to include antibody therapy, particularly with rituximab have given substantial increases in the complete response rate for CLL patients.4, 7-11 and an indication of increased overall survival in response to fludarabine-cytoxan-rituximab (FCR) therapy.12 Nevertheless, relapses remain problematic and development of drug resistance continues to be a major challenge in CLL treatment.11. Such drug resistance may in part be due to certain genetic alterations. A deletion at 11q22-23, the site of the ATM gene, occurs in half of relapsed/refractory patients. Mutation of the residual allele in approximately 50% of these patients inactivates homologous recombination (HR) repair of double strand breaks in CLL cells. Because Sapacitabine causes one-ended double strand breaks, cells that lack ATM are selectively sensitized. We hypothesize that the novel mechanism of action of Sapacitabine in CLL cells that lack ATM function, and are therefore are in repairing the lesion by homologous recombination, will create synthetic lethality and confer specificity of killing. We will conduct a clinical trial of Sapacitabine combined with cyclophosphamide and rituximab in relapsed/refractory patients with CLL who exhibit deletion 11q22-23 with the following specific aims: 1) test the hypothesis that CLL lacking ATM function (homologous recombination repair) will be selectively sensitized to Sapacitabine- containing therapy as indicated by a greater overall response rate and longer response duration; 2) identify CLL patients whose disease lacks ATM function, and analyze clinical response with respect to this parameter. Demonstrating efficacy in patients with deletion 11q22-23, lacking ATM function, would be a significant advance in treatment for this high-risk group of patients, and would validate ATM as a target for Sapacitabine- containing therapy in CLL, and 3) conduct investigations with CLL samples obtained from patients entered on the trial that will translate the findings in models systems to these primary CLL cells.

Public health relevance
PUBLIC HEALTH RELEVANCE: Patients with CLL who have leukemia cells with deletion of the long arm of chromosome 11 (11q), the location of the ATM gene, are high-risk for rapid disease progression, short remission duration, and short overall survival. The function of ATM is critical to repairing breaks in DNA and is frequently lost in this group of patients. This applicaton proposes to treat these patients with Sapacitabine, a drug that causes DNA strand breaks, with the view that the leukemia cells that lack ATM function will be specifically affected, resulting in improved clinical responses and remission rate. __SpecificAimsTextDelimiter__ Specific Aims There has been remarkable progress in the treatment of CLL during the last decade. The introduction of fludarabine and other purine nucleoside analogs generated a significant improvement in responses relative to alkylating agents.1-3 Subsequently, clinical response to combinations of these two classes of agents, in particular the mechanism-based couplet of fludarabine and cytoxan which are synergistic in vitro,2-4 were proved superior to single agent fludarabine.5-7 Recently, strategies to include antibody therapy have given substantial increases in the complete response rate for CLL patients.5, 8-11 and an indication of increased overall survival in response to fludarabine-cyclophosphamide-rituximab (FCR) therapy.12 Nevertheless, relapses remain problematic and development of drug resistance is a major challenge in CLL treatment.13 Although 10-20% of previously untreated patients with CLL exhibit a substantial deletion in the q arm of chromosome 11, the site of the ATM gene at del(11q22.3).14 This lesion occurs at increased incidence (~50% in patients relapsing on FCR chemoimmunotherapy.15 The residual ATM allele is often mutated,16 suggesting that the region containing ATM is important for response to chemoimmunotherapy. Importantly, our recent findings indicate a novel mechanism of action of the deoxycytidine analog CNDAC (2'-C-cyano-2'-deoxy-1-β-D- arabino-pentofuranosylcytosine) (Fig. 1) that selectively sensitizes cells that lack ATM function.17, 18 After phosphorylation, the triphosphate is incorporated into DNA19 and spontaneously decomposes to generate a single strand break in DNA20 which is converted to a one-ended double- strand break upon collapse of the DNA replication fork.18 This is repaired by the homologous recombination pathway, which requires ATM activity.21, 22 The viability of cells that lack this pathway is sensitized as much as 100-fold to CNDAC.18 As only one end of double-stranded DNA is present, this lesion is not a substrate for non- homologous end-joining repair.23 Sapacitabine, the orally bioavailable clinical formulation of CNDAC, in relapsed/refractory acute myeloid leukemias and myelodysplastic syndromes.24 We hypothesize that the novel mechanism of action of sapacitabine in CLL cells that lack ATM function, which are therefore incapable of repairing the lesion by homologous recombination, will create synthetic lethality and confer specificity of killing against ATM-deficient CLL cells. We will translate our laboratory results into a clinical trial of sapacitabine to test this hypothesis in patients with relapsed/refractory CLL that exhibit a deletion in the q arm of chromosome 11, [del(11q22-23). We will support the results of clinical trial with laboratory correlative investigations that will enable determination of the role of ATM function with regard to clinical responses. Fig. 1. Structures of dCyd and its analogs. Aim 1. Test the hypothesis that CLL patients with del(11q22-23) that lack ATM function will be selectively sensitized to Sapacitabine-containing therapy. It is estimated that as many as half of CLL patients refractory to prior therapy, whose disease exhibits del(11q22-23), lack ATM gene function. Patients with this genetic lesion will be eligible for a clinical trial of sapacitabine in combination with rituximab and cyclophosphamide, an alkylating agent that stimulates excision repair processes to facilitate incorporation of sapacitabine into DNA. Our goal is to determine safety, to compare the overall response rates and time to treatment failure, and to establish proof-of-principle that lack of ATM function will improve clinical responses. Aim 2. Identify CLL patients who lack ATM function. We have developed an assay of ATM functionality in the residual allele in pre-treatment CLL cell samples from patients exhibiting del(11q22-23). We will apply this assay to determine ATM functionality of the fresh CLL samples from patients entered on this clinical trial. Sequencing of the ATM gene will be conducted to establish concordance between functionality and mutations. Aim 3. Investigate the actions of Sapacitabine/CNDAC in primary CLL cells that lack ATM function. To establish proof-of-principle, we will translate investigations of the action of CNDAC from model cell lines into primary CLL samples for in vitro investigations. CLL cells will be stimulated to divide in vitro to provide a working model of the incorporation of CNDAC into DNA during replication, and to study the sequelae as cells progress to a second DNA replication. A second approach will compare the ability of different DNA damaging agents to induce excision repair in CLL cells that would facilitate incorporation of CNDAC nucleotide. This could guide the design of future combinations. Evidence of CNddC formation following stimulation to proliferate will be sought. Success of these investigations will provide rationale for extension of sapacitabine therapy to other malignancies that are deficient in homologous recombination function.